Statistical Methods to Leverage Immunologic Biomarkers and Complex Molecular Testing Data for Respiratory Diseases Vaccines Development

Project Summary/Abstract
Vaccine efficacy (VE) trials are the gold standard to determine the VE, relative VE, and VE durability. In
addition, VE trials generate rich data for characterizing and comparing vaccine-induced immune responses
and correlating immune responses to the clinical outcome. An immune correlate of risk (CoR) is a biomarker
predicting clinical endpoint risk within a single treatment arm, while a correlate of protection (CoP) builds on
a CoR to reliably predict VE or relative VE. Established CoR/CoP analyses have deepened our understand-
ing of the causal mechanism through which vaccine works and accelerate vaccine approval. Our extensive
experience emphasizes three key aspects of recent and ongoing VE trials: First, these trials target di-
verse populations with varying baseline immunity from prior exposures or vaccinations. Second, emerging
variants can evade natural or vaccine-induced immunity, prompting the inclusion of variant-specific inserts
in updated vaccines. Third, advanced diagnostic technologies, such as multiplex PCR tests used in the
COVE trial, enable simultaneous detection of multiple pathogens triggering illness visits. This project aims
to develop analytical tools to address these challenges by leveraging rick immune biomarker and clinical
endpoint data. First, we will develop an immunogenicity model that seeks to make the best prediction of an
individual’s post-vaccination immune biomarker given their baseline immune biomarker from the same im-
munoassay and key demographic variables, and we will use this model to unpack how VE is modulated by
baseline immunity. Second, we will develop scalable and efficient statistical tests for a “conditional variant-
invariant model” across different vaccine platforms and develop robust estimators of relative VE for updated
vaccines compared to approved ones against variant pathogens. Lastly, recognizing that vaccines have a
null effect on vaccine-mismatched respiratory disease endpoints, we will create a statistical framework to
mitigate bias in VE durability and immune correlates analyses using well-defined off-target endpoints from
novel multiplex PCR tests. Successful completion will equip investigators with innovative tools to extract
more knowledge from VE trials.

Public health relevance
Project Narrative This project aims to improve our understanding of how vaccines work by developing new statistical tools to analyze data from vaccine efficacy trials. The proposed methods will help predict how individuals with different baseline immune profiles respond to vaccines and how emerging variants affect vaccine efficacy. Additionally, the project will create techniques to reduce bias in vaccine durability analyses by using ad- vanced diagnostic tests. These innovations will support better vaccine design and decision-making, ulti- mately enhancing public health outcomes.